Human Phenotyping Core

Human Phenotyping Core Project Summary
This highly successful Human Phenotyping Core focuses on providing Center investigators with access to
state-of-the-art technologies and methods for utilizing multi-parameter, high-content approaches to assess
molecular phenotypes for rheumatic disease research. This Core coordinates expertise and core competencies
in transcriptomics, proteomics, high-content cellular immunophenotypes, single-cell multiomics and tissue-
based spatial multiomics. As such, it continues as a resource where ORDRCC Investigators can generate,
share and analyze the multi-dimensional molecular phenotype data necessary for developing competitive
research programs. Beyond giving ORDRCC investigators access to advanced technologies that are currently
established at OMRF, this Core offers newly developed services providing access to data analytics in single-
cell multi-omics from blood or dissociated tissue, as well as spatially aware tissue-based single-cell
approaches. Our platforms enable investigators to define patient molecular profiles based on genetic,
transcriptome, cellular, and/or proteomic differences in specific cell populations, as well as at the individual cell
level with single cell 10X Genomics multiomic approaches, either 3’ or 5’ scRNA-seq/high-plex CITE-seq +
BCR/TCR repertoire, or snRNA-seq/snATAC-seq for epigenetic analyses. Currently evolving approaches using
fixed cells or fixed tissue dissociated to single cells on the Chromium X platform offer additional options for
difficult to obtain cell populations from existing archival pathology samples in some cases. Spatial technologies
have also advanced significantly and include multiomic (transcript and protein biomarkers) approaches.
Capitalizing on the magnitude of information available through our carefully processed, well-organized,
clinically characterized samples; our ability to provide comprehensive multi-analyte molecular phenotype
profiles provide a foundational resource for identifying new research directions and generating new ideas for
future collaborative projects. Aims of the updated Human Phenotyping Core are: AIM 1: Assist ORDRCC
Investigators, JCIs and Scholars to navigate the stages of project development, experimental design, resource
planning and execution of translational and mechanistic studies through Core Management and individual
consultations, AIM 2: Provide access and training in use of molecular single-cell and spatial multiomic
technologies using the technical personnel experienced in these advanced approaches, AIM 3: Establish data
analytics pipelines for quality control, dataset generation and advanced modeling of single-cell and spatial
multiomic data, and molecular phenotyping for patient stratification, AIM 4: Evaluate, assess and implement
emerging technology and analytics approaches to more accurately assess patient heterogeneity in disease
presentation and treatment responses. The HPC evaluates new technologies, working with the institution to
secure new equipment or helping investigators understand the strengths and weaknesses of new technologies.
The HPC also provides education for JCIs, Scholars, center investigators and lab personnel in these areas.